Development of a multispecies live biotherapeutic product for the prevention of recurrent bacterial vaginosis

Abstract
Recurrent bacterial vaginosis (rBV) is the most common vaginal disorder among women of
reproductive age and is caused by a loss of protective Lactobacillus bacteria and overgrowth of
harmful bacteria (i.e. vaginal microbiota dysbiosis). While antibiotics can treat BV, they do not
solve the underlying dysbiosis that contributes to the high rate of 50% recurrence within one
year. Recurrent BV is associated with increased risk for a myriad of serious health
complications, including STIs, HIV, and adverse pregnancy outcomes. Surprisingly, there are no
approved therapies for preventing rBV. To address this unmet need in women’s health, we will
build a live biotherapeutic product (LBP), STMC-105, a multispecies vaginal bacteria therapy
designed to enhance durable Lactobacillus colonization and prevent rBV. STMC-105 will
combine multiple protective Lactobacillus species (L. crispatus, L. gasseri, and L. jensenii) to
support synergistic functionality and to address population diversity. We will take a systematic
approach by selecting high-performing strains based on their potential to adhere to mucosal
surfaces, reduce the burden of opportunistic organisms, metabolically cross-feeding on vaginal
carbohydrates (SA1.1), and reduce vaginal cell inflammation (SA1.2). After optimal
Lactobacillus strain selection, we will develop coculture conditions to prime cells for vaginal
carbohydrate cross-feeding (SA2.1) and formulate live cells into a mucoadhesive extended-
release vaginal tablet (SA2.2) to enhance vaginal colonization and potential to mitigate rBV.
These developments will provide the foundation for clinical validation preparations (SA3.1) and
support regulatory submissions (SA3.2) to evaluate the safety and efficacy of STMC-105 in a
first-in-human clinical trial. The ultimate goal of this work is to develop an FDA approved LBP
for the prevention of rBV. Such a product proven to be safe and efficacious would alleviate a
significant gap in women's health and improve long-term outcomes for millions of people.

Public health relevance
NARRATIVE An imbalance of the vaginal microbiota is the underlying cause of recurrent bacterial vaginosis. We are developing a live biotherapeutic containing multiple types of protective vaginal bacteria to durably colonize the vaginal tract and prevent bacterial vaginosis. We will complete selection of active ingredient bacteria, optimize manufacturing for an extended-release vaginal tablet, and prepare for a first-in-human clinical trial and investigational new drug application with FDA.